The Synergistic Effects of Menopause and HIV on Cardiovascular Disease Risk in Women

Project Summary/Abstract
Understanding the contribution of menopause to clinical outcomes in HIV is an emerging health priority. There
are over 20 million girls and women living with HIV (WWH) worldwide and over 50% of WWH in the US are
experiencing the transition to menopause, a multi-year period characterized by declines in ovarian reserve that
spans the premenopausal, perimenopausal, and postmenopausal phases. Perimenopause is a time of increased
multi-morbidity risk, highlighting its importance as an optimal time for preventive interventions. HIV and
menopause are independently associated with a higher burden of cardiovascular disease (CVD) and other
comorbidities, but it is unclear whether HIV and menopause have synergistic effects. Studies of menopause in
WWH have been impeded by the irregular menses and amenorrhea caused by chronic illness. As a result, it is
unclear how menopause impacts CVD risk in WWH and whether perimenopause is a critical period for CVD
prevention in WWH. This proposal leverages the NHLBI-funded MACS/WIHS Combined Cohort Study, which
serially measures anti-Müllerian hormone, a biomarker of ovarian reserve, to precisely determine the pre-, peri-
, and postmenopausal phases. The overall objective of this proposal is to determine the contribution of HIV and
menopausal phase to CVD risk parameters (e.g., insulin resistance, lipids, hypertension) and subclinical
atherosclerosis, and to examine the influences of immune activation and adiposity. The specific aims are (1) to
determine the association of HIV and menopausal phase with CVD risk parameters; (2) to evaluate the
association of HIV and menopausal phase with immune activation and whether immune activation mediates
subclinical atherosclerosis using carotid imaging; and (3) to examine the association between MRI-measured
adipose tissue volume and immune activation across the menopausal transition in WWH. Determining whether
menopause and HIV have a synergistic effect on CVD risk could reveal mechanisms that drive CVD in WWH
and identify therapeutic targets to prevent CVD. This K23 proposal also supports the career development of Dr.
Rebecca Abelman, Assistant Professor of Medicine at the University of California San Francisco. Dr. Abelman’s
long-term goal is to become an independent investigator studying ovarian aging and its role in comorbidity burden
and organ dysfunction in WWH. Her short-term career goal is to examine the effect of menopausal phase on the
development of cardiometabolic outcomes in WWH. To achieve her career goals, Dr. Abelman proposes training
in (1) biomarker testing, analysis, and interpretation; (2) causal mediation and longitudinal data analysis; (3)
imaging in patient-oriented studies of menopause and comorbidities; and (4) leading independent ancillary
studies in large observational cohorts. To help guide her transition to career independence, Dr. Abelman has
assembled a highly experienced mentorship team with deep expertise in HIV, menopause, the inflammatory
consequences of HIV infection, biomedical imaging, and biostatistics.

Public health relevance
Project Narrative As over half of women with HIV in the United States are transitioning to menopause, understanding the contribution of menopause to aging-related comorbidities in women with HIV is an emerging health priority. This project leverages a large, long-standing national cohort of adults with and without HIV to understand the contribution of menopause to cardiovascular disease risk in women with and without HIV.